Identification of molecular glues targeting FoxP3 to modulate Treg suppressive function and enhance anti-tumor immunity

Project Summary
Cancer remains one of the leading causes of death worldwide despite advances in diagnoses and
treatments. Immunomodulatory therapeutics like anti-PD-L1 and anti-PD1 enhance the host immune response
against the tumor and have saved countless lives. However, these treatments only work a small fraction of the
time. Immunosuppressive T-regulatory cells (Tregs) have come under scrutiny as the ratio of Tregs in the tumor
microenvironment can dictate both clinical prognoses and whether a patient responds to immunotherapy
treatment. Furthermore, current therapeutics to target Treg suppressive function, directly or indirectly, remain
unspecific and transient with an extremely low efficacy. Therefore, new therapeutics need to be developed
against Tregs and Treg suppressive function.
Forkhead box protein 3 (FoxP3) is a Treg and Treg suppressive function specific target. FoxP3 is not only
a lineage defining marker in Tregs, but also the master regulator of Treg differentiation and function. Given the
role of FoxP3 as a transcription factor though, FoxP3 is known to be “notoriously undruggable” due to both its
nuclear localization and lack of inhibitable binding pocket. Fortunately, our lab and others have shown chemically
targeting the ubiquitin proteasome system (UPS) can regulate FoxP3 protein levels, and in turn, modulate Treg
suppressive function. Unfortunately, UPS enzymes have wide substrate diversity and broad cell type expression,
leading to off-target effects. However, through using small molecule compounds known as “molecular glues,” we
can specifically glue FoxP3 with E3 ligases to promote its targeted proteasomal degradation.
My preliminary data identifies and characterizes one lead small molecule compound as a FoxP3 degrader.
First, using a FoxP3-GFP reporter system, 81 potential hits were identified from 640 small molecule library, which
reduced FoxP3. Following a secondary dose-response screen, an additional screen by flow cytometry in human
Treg-like MT-2 cells, and resynthesis of four potential lead compounds, one lead compound, termed MG03, was
identified. MG03 was found to decrease FoxP3 in MT-2 cells as well as mouse primary Tregs, and my preliminary
data suggests that MG03 promotes proteasomal degradation of FoxP3. Thus, the long-term goal of this proposed
project is to further develop this lead compound to target Treg suppressive function in the context of cancer.
The central hypothesis for this project is that Tregs can be targeted through FoxP3 by small molecular
degraders to partially diminish Treg suppressive function and enhance the anti-tumor response. To test this
hypothesis, we will address the following aims: Aim 1 will determine efficacy of the lead compound, MG03, in
inducing FoxP3 degradation in vitro; Aim 2 will investigate the underlying mechanisms of MG03; and Aim 3 will
evaluate efficacy of MG03 on Treg suppressive function in vitro and in vivo. This study will identify the first
FoxP3-specific molecule glue to partially diminish Treg suppressive functions for cancer treatment.

Public health relevance
Project Narrative This project seeks to identify and develop novel small molecule degraders of FoxP3 to target Tregs, diminishing Treg suppressive function, and increase the anti-tumor immune response. Our short-term goal is to provide rationale for targeting FoxP3 by small molecular glue degraders; and our long-term goal is to develop immunomodulatory therapeutics by harnessing the ubiquitin pathway.